Computation and Data Management

PROJECT SUMMARY: COMPUTATION & DATA MANAGEMENT SERVICE MODULE
The Vanderbilt Vision Research Center (VVRC) includes faculty investigators with strong interest in high-
level imaging of visual cognition in humans, multi-electrode array neurophysiology, large-scale human
bioinformatic datasets, visual behavior in awake-behaving non-human primates, and computational modeling
of human and non-human primate vision. These clinical, cognitive- and systems-level investigations require
expertise in computer systems administration, data collection and management, analysis, and storage, and
web-based applications for experimentation. As well, other VVRC investigators require access to hardware and
software maintenance and specialty programming, including web-based content and interfacing with specialty
equipment made in our instrumentation service module. The purpose of the VVRC Computation & Data
Management Service Module is to provide a comprehensive service for computer hardware and software that
support the wide range of empirical studies our investigators conduct. The Computation & Data Management
Module provides computer technology support for research needed to solve more complex challenges that
face computer-dependent laboratory science. This module is a VVRC-intrinsic core and is not part of a VUMC
institutional facility; therefore, the service is provided to VVRC members by request and not through the VUMC
Office of Research scholarship platform. In the current funding period, the computation module directly
supported 213 publications involving 23 VVRC faculty authors, including 8 of 16 current NEI R01 holders,
excluding website maintenance. These are indicated as such in our Progress Report: Core Vision Publications
by Investigator document. A survey of researcher plans indicates that the use of this service will increase, with
moderate to extensive use by 24 of 52 VVRC faculty, including 11 of 16 current NEI R01 holders. The module,
housed in approximately 500 sq ft of office, server, and storage space in Wilson Hall proximal to VVRC
investigators is directed by VVRC Investigator Frank Tong, PhD (NEI R01). Using this space and personnel
supported by this Core mechanism, the VVRC Computation & Data Management Module will: (1) provide
hardware and software support of VVRC investigations, (2) provide data pipeline, archiving, and storage
solutions, (3) provide custom programming solutions, and (4) facilitate web-based content and interfacing.
These services and resources will enhance the scope of experimentation NEI-funded VVRC investigators
conduct, promote innovation through the provision of custom hardware and software resources, and enhance
collaboration by providing computation and data management support to those who otherwise would not have
such capabilities, including early-career vision scientists, clinician-scientists competing for extramural funding
for their laboratories, and VVRC investigators without access to computer expertise beyond basic internet
technology services.